Tracer harmonization for amyloid and tau PET imaging using statistical and deep learning techniques

PROJECT SUMMARY/ABSTRACT
Amyloid and tau are two hallmark pathologies of Alzheimer's disease (AD), which start to accumulate in the brain
long before clinical symptom onset. With the recent development of positron emission tomography (PET) tracers,
in vivo measurements of these two pathologies became possible and play important roles in improving our
understanding of AD pathogenesis and progression, and provide critical diagnostic and prognostic information
that can facilitate the treatment development effort now and improve patient outcome when effective treatments
become available. However, multiple PET tracers exist for both amyloid and tau imaging and generate images
that have different visual appearances and quantitative characteristics. These differences lead to difficulties in
comparing different studies, leveraging the large volume of data that have been collected to date, and defining
a common criterion for positivity. In this project, we will focus on the development of novel techniques that can
harmonize PET imaging data and generate highly compatible imaging derived measurements. We argue that by
adopting advanced statistical and deep learning techniques and developing novel quantification strategies that
take full use of the available information in imaging data, successful harmonization can be achieved via
generalizable approaches. Several lines of research support this argument: 1) we recently demonstrated that
using partial volume correction technique to reduce white matter signal contamination, improved agreements in
amyloid burden measurements derived from PIB and florbetapir can be obtained; 2) in our preliminary analysis,
using machine learning technique, we can substantially improve between-tracer agreements in global amyloid
burden; 3) recent advancement in deep learning research demonstrated the ability to “impute” one imaging
modality from another by taking advantage of the inherent information in large imaging datasets, and our
preliminary results demonstrated its potential in image harmonization tasks. In this project, we will continue this
research and develop a set of techniques that can be used to harmonize amyloid imaging data from different
tracers and extent this approach for tau PET harmonization. Our specific aims are 1) to develop deep learning
models that can generate imputed amyloid PET images from one tracer based on the images from another tracer;
2) to develop statistical learning approaches that can generate harmonized amyloid burden measurements; 3)
to acquire head-to-head comparison tau PET imaging data and examine statistical and deep learning
approaches to the harmonization of Tau PET imaging data.

Public health relevance
NARRATIVE Having multiple PET imaging tracers for amyloid and tau facilitates their wide application but also poses a challenge on how to interpret the imaging results in a unified fashion and makes it difficult to leverage the large datasets that are available. We propose to use advanced statistical and machine learning techniques to explore the rich information inherently available from imaging data which allow the derivation of harmonized imaging- based measurements globally and locally. We will also acquire a head-to-head tau PET imaging dataset to enable the development and validation of our proposed techniques for tau PET imaging and make it available to the broad research community.